Instrumentation Module

Program Director/Principal Investigator (Last, First, Middle): Abstract The Instrumentation Module provides design, fabrication and modification capabilities for project-specific, customized and software-flexible vision research apparatuses that are not commercially available. During the past five years, the Module fabricated many in-house, tailor-fitted and specially-designed devices that have played crucial roles in generating many high-impact and innovative vision research results. In the next grant period, this Module will continue its indispensable role in supporting vision research projects by providing new mechanical, electronic, optic and computer-based design and fabrication services and to develop highly innovative, high-impact research tools, such as the chronically implanted tetrode array recording chambers, the virtual reality visual-vestibular stimulating system, and the forced-choice, Bayesian adaptive protocol-driven optokinetic reflex machine. All these devices will be constructed and repeatedly modified, fitted and adjusted before and during experiments by the in-house machine shop and electronic/optics/computer shop. Therefore the Instrumentation Module is not only a necessity of many Vision Core labs, but also an integrated part of the research process and scientific progress. PHS 398/2590 (Rev. 11/07) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): The Instrumentation Module of the Vision Core designs and fabricates vision research instruments that are not commercially available. These instruments are used to study how visual system disorders, such as age-related macular degeneration, glaucoma, amblyopia and strabismus occur and what neuronal mechanisms in the visual system are responsible for the pathogenesis of these disorders. The Module also constructs devices for early detection of visual system defects and disease. PHS 398/2590 (Rev. 11/07) Page Continuation Format Page